Vestibular Precision: Physiology and Pathophysiology

Project Summary (copied from parent R01 DC018287)
The goal of this proposal is to investigate vestibular precision by quantifying the variability in behavioral
responses that result from the neural noise inherent to the peripheral and central vestibular systems. Because
neural noise contaminates the signals that are transduced by the ear and processed by the brain, vestibular-
mediated behavioral responses vary even when identical stimuli are provided. In this proposal, we focus on
vestibular precision in human subjects and investigate its sources, its effects on behavior, and its degradation
when the periphery is damaged and its potential plasticity. Specifically, we will investigate:
SA 1: Vestibular precision in normal subjects – physiology: A) We will measure the angular and linear
vestibulo-ocular reflex (VOR) using novel motion combinations that reinforce or cancel eye movement
responses, which will allow us to determine the distribution and magnitude of noise produced in the sensory
(canal, otolith) pathways and in the oculomotor pathway. We hypothesize that normal subjects will demonstrate
a bimodal distribution of noise with either sensory or motor predominance, and that subjects with more sensory
noise will demonstrate other behavioral characteristics that reflect this characteristic (e.g., higher perceptual
thresholds); and B) We will assay vestibular noise from trial-trial variations in the VOR and will compare VOR
dynamics with those predicted by a Bayesian model using the assayed noise. We predict variations in VOR
dynamics across subjects, age and stimulus amplitudes will be consistent with Bayesian processing of noise.
Potential confounding factors will be carefully controlled, including attention, fatigue, and non-vestibular cues.
SA 2: Vestibular precision after peripheral damage – pathophysiology: A) We will examine the changes in
vestibular precision that occur when one vestibular nerve is damaged (by a vestibular schwannoma, VS) and
after the damaged nerve is surgically sectioned, and will investigate if precision measurements can provide
evidence of pathologic noise produced by the damaged nerve and therefore help predict clinical outcome when
the nerve is sectioned. We hypothesize that changes in signal reliability due to the VS will be traceable to both
the reduced redundancy caused by loss of afferent fibers and to aberrant noise generated by the damaged
vestibular nerve and that changes in precision after neurectomy will correlate the outcome measures that
characterize patient disability; and B) We will examine the plasticity of vestibular precision in the oculomotor
and perceptual realms with the goal of determining if precision can be improved. Using novel training
approaches that provide challenging signal extraction tasks, we hypothesize that subjects will improve their
vestibular precision on the trained task. As secondary outcome measures, we will determine if training one
behavior generalizes to the non-trained behavior and if patient’s symptoms are affected by improved precision.

Public health relevance
This project will investigate the role of noise in the vestibular system, and in particular its effects on the variability (precision) of vestibular-mediated behaviors. We will study vestibular precision in normal subjects and patients with peripheral vestibular damage, and will investigate its potential plasticity. The goals are to develop a better understanding of the role played by noise in the vestibular system in normal and pathologic populations, and to determine if the brain can learn to improve signal recognition within its inherently noisy neural environment, which would result in improved behavioral precision.